Improving Person-Environment Fit of Community-Residing Older Adults with Dementia Through Assessment and Individualized Intervention

Project Summary
Aging with Alzheimer's disease and related dementias (ADRD) is compounded by onset of behavioral and
psychiatric symptoms (BPSD) seen in over 80% of those with the condition. BPSD often precipitate caregiver
burden, institutionalized care, and increased rates of mortality. Despite the critical need, there currently are few
non-pharmacological interventions to manage BPSD and those that exist have weak evidence. Research: The
project titled, Improving Person-Environment Fit of Community-Residing Older Adults with Dementia Through
Assessment and Individualized Intervention, identifies person-environment relationships as a mechanism of
action to guide assessment of and intervention for functional behavior within the home context for persons with
ADRD. By improving the relationship between persons with ADRD and their home environment (person-
environment fit), it is hypothesized that people with ADRD will have improved BPSD and activity engagement
within their home. We will employ the NIH Stage Model of Behavioral Intervention Development to define
assessment of person-environment fit (Stage 0; Aim 1) and pilot the feasibility of a telehealth intervention to
maximize person-environment fit within the homes of community-residing adults with ADRD within rural
communities (Aim 2). Findings of this research will inform discovery of best practices for a non-pharmacological,
environmental approach to BPSD for persons with ADRD living in their home. Candidate: Dr. Elizabeth Rhodus
is an early-career investigator, who is transitioning from a NIH T32-funded postdoctoral fellowship to a full-time
tenure-track faculty position at the University of Kentucky (UK) College of Medicine. Three training goals will
enhance her trajectory toward becoming an independent, successfully funded investigator: 1) Develop a strong
knowledge base on integrated physiological and behavioral assessment of person-environment interactions on
community-dwelling people living with ADRD, 2) Build expertise in development and implementation of
behavioral interventions among older adults with ADRD, and 3) Expand understanding of research strategies for
inclusion of underrepresented populations in aging studies. Mentors/Environment: The current career
development plan includes substantial mentorship, didactic training, and experiential learning at the UK Center
for Health Equity Transformation with Director, Dr. Nancy Schoenberg (primary mentor), UK Sanders-Brown
Center on Aging with Associate Director, Dr. Donna Wilcock (co-mentor), Dr. Anton Porsteinsson (mentor), a
prominent clinical researcher and psychiatrist for treatment of BPSD, and a renowned, interdisciplinary advisory
committee. Dr. Rhodus will receive support from her institution through internal grants, faculty education,
networking, and scholarship. Dr. Rhodus has full support from UK (see institutional letter of support) to advance
her career development and research activities. Thus, the overall objective of this K23 application is to propel
the career development of Dr. Rhodus to an independent scientist in ADRD research using the findings of this
project to inform a future extramural R01 targeting non-pharmacological interventions for BPSD management.

Public health relevance
Project Narrative The short-term goal of this K23 award is the development of the PI as an independent investigator skilled in the assessment and behavioral intervention, most especially focused on underrepresented and vulnerable aging populations, in rural regions who are disproportionately impacted by dementia. The proposed research will use a non-pharmacological, environmental approach to develop assessments and tailored interventions that can be delivered via telehealth to improve behaviors and activity engagement for people with dementia in their home. The long-term goal is to empower older adults with dementia to age in place within their home with minimal behavior disruption and maximum activity participation.